Whole Genome Sequencing

WA PHL is the clinical reference lab for the state of Washington, and is the Western Region Reference Laboratory for both APHL PulseNet and OAMD activity, placing WAPHL in a unique position to assist in sequencing of non-clinical pathogens found in human or animal foods, in the environment of institutions, and in water samples. WAPHL is poised to continue contributing to this project’s goal, to survey the diversity of non-clinical pathogens present in the state of Washington. WA PHL will use this funding opportunity to build relationships with state and regional facilities, to provide FDA-CFSAN support for pending sequencing projects, and to sequence non-clinical isolates from a variety of submitters.

Public health relevance
WA PHL is the clinical reference lab for the state of Washington, and is the Western Region Reference Laboratory for both APHL PulseNet and OAMD activity, placing WAPHL in a unique position to assist in sequencing of non-clinical pathogens found in human or animal foods, in the environment of institutions, and in water samples. WAPHL is poised to continue contributing to this project’s goal, to survey the diversity of non-clinical pathogens present in the state of Washington. WA PHL will use this funding opportunity to build relationships with state and regional facilities, to provide FDA-CFSAN support for pending sequencing projects, and to sequence non-clinical isolates from a variety of submitters.